Enhancement of Optometric Education with Basic, Applied and Clinical Research

T35 Program Plan
Enhancement of Optometric Education with Basic, Applied and Clinical Research
Abstract
The T35 Training Grant titled, Enhancement of Optometric Education with Basic, Applied and
Clinical Research, seeks to afford qualified Optometry Interns the opportunity to pair with
experienced research faculty to conduct basic, applied, clinical and translational research at the
University of the Incarnate Word Rosenberg School of Optometry (UIWRSO). Objectives
include (a) Faculty-Intern research committed to early detection, diagnosis, and treatment of
ocular disease as well as basic and applied research which enhance our understanding of visual
function leading to improvement of vision in normal and abnormal populations (b) inspire
Interns to pursue postdoctoral research and academic activities and positions paving a course
toward academic and research careers (c) foster collaboration with other UIW programs (Schools
of Medicine, Pharmacy, Physical Therapy, Nursing, Math, Science and Engineering and
Biomedical Sciences) as well as institutions and industry sharing common goals. The rationale
for our proposal is predicated on our success with our Summer Fellowship Training Program
(SFTP), active since 2011, allowing Interns to participate in faculty supervised research during
the summer between first and second professional years. The SFTP has been highly successful
yielding 17 peer-reviewed papers and 60 peer-reviewed poster and paper presentations at major
meetings comparable to or exceeding major schools and colleges of optometry funded with T35
grants. While the SFTP is largely internally funded, previously supplemented by industry and a
grant to increase diversity in optometric education, it closely mirrors current T35 programs, and
we hope to continue our success. We propose that a T35 grant support four Interns per year for
8-week summer periods for a duration of five years.

Public health relevance
T35 Program Plan Enhancement of Optometric Education with Basic, Applied and Clinical Research Narrative Our proposed T35 Training Grant will afford Faculty mentored research training to four Optometric Interns per year for 8-weeks during summer between the 1st and 2nd year of their professional education. It will perpetuate and enhance our current highly successful Summer Fellowship Training Program.